Core D: Clinical Research

PROJECT SUMMARY/ABSTRACT
The Clinical Research Core (CRC) (Core D) provides services to support researchers conducting human
subjects research studies investigating the pathogenesis of HIV disease, treatment and prevention of HIV,
strategies to eliminate HIV from those who are infected, and the reduction of the long-term morbidity among
those with HIV infection. The Clinical Core will enable the conduct of scientifically rigorous HIV clinical and
translational research through the provision of state-of-the-art research infrastructure including shared
research space, laboratory services, and expert consultation in clinical research methods and study
implementation. To support investigators engaged in these activities the Core will expand the use of a
sophisticated clinical database, the “HIV Disease Registry” (>32,031 unique patients cared for at Emory-
associated facilities, with 6,066,481 patient encounters representing over 123,972 person years of clinically
relevant data). The CRC will provide access to a diverse array of biological specimens and data from
populations traditionally under-represented in HIV research, including minority women, adolescents, pregnant
women, and minority men who have sex with men. The Core's specimen repository provides access to
specimens and data from populations critical to high priority research questions, including elite controllers,
long-term non-progressors, people with acute HIV infection and/or acute HCV coinfection, and high-risk sero-
negative men and women. The Core will foster career development of ESI and scientists new to HIV
translational research. The CRC proposes the following Specific Aims:
Aim 1. Facilitate the conduct of groundbreaking and community-responsive HIV clinical research via state-of-
the-art research infrastructure, expansion of services to advance pediatric and adolescent research, and
collaboration with the CFAR Community Liaison Council for greater harmonization of multiple community
advisory boards to promote greater community engagement in all aspects of clinical research.
Aim 2. Expand the use of the HIV Disease Registry to enhance international data sharing, expand data
collection from Grady's pediatric and adolescent population, and add data from Emory Healthcare.
Aim 3. Provide access to data-linked biological specimens from diverse populations, including
underrepresented groups in HIV research; renew the focus on children, adolescents, and young adults, while
continuing to strengthen the participation of women; and expand our biobank for emerging research such as
SARS CoV-2/HIV coinfection and vaccines.
Aim 4. Foster career development for the next generation of HIV researchers through Core services and
programs and through collaboration with the Developmental Core.